Prioritizing autoimmune-associated genetic variants that alter regulatory element activity in B cells

SUMMARY
Genome-wide association studies have discovered hundreds of genetic loci throughout the genome that
associate with autoimmune diseases. However, the causal genetic variants that drive autoimmune disease in
each locus are for the most part unknown. It is difficult to identify the causal variant(s) in each locus because 1)
there is often tight linkage disequilibrium between causal variants and tens to hundreds of non-causal variants,
making it difficult to determine which variant is indeed causal, and 2) because most genetic associations occur
in non-coding regions, where their actions on disease-relevant genes and cell types are hard to determine.
However, variants are enriched in non-coding candidate cis-regulatory regions that may modulate gene
expression of disease-relevant genes. Autoimmune genetic variants enrich highly in B cell accessible chromatin,
indicating that variant modulation of cis-regulatory activity in this cell types may be important for disease
progression. One way to determine the variants that can alter cis-regulatory activity is through testing them in
massively parallel reporter assays, which can test thousands of variants in one assay for their ability to alter
reporter expression in an allele-specific fashion. This approach is highly effective, as we have found variants that
altered reporter expression enrich up to 58-fold for causal variants (according to statistical fine-mapping). In this
proposal, we will apply MPRA in B cells to test ~18,000 variants associated with type 1 diabetes, multiple
sclerosis, inflammatory bowel disease, rheumatoid arthritis, and psoriasis for their ability to alter reporter
expression. To ensure B cell MPRA hits are relevant for autoimmune disease, we will assess whether they enrich
for causal variants according to statistical fine-mapping. We will rank variants according to their allelic bias effect
size and choose 3 high effect variants for further mechanistic follow-up. For each of the 3 variants, we will base
edit variant alleles into primary naïve B cells from healthy donors and observe effects on local B cell gene
expression (within 1 Mb of variant), cytokine secretion, and markers of B cell differentiation. For 1-2 variants
where we find base editing to alter B cell phenotypes, we will identify homozygous risk and non-risk allele carriers
for both healthy subjects and subjects with autoimmune disease within the Benaroya Research Institute
biorepository. We will assess whether variants correlate with altered B cell phenotypes, testing whether risk vs.
non-risk variant carriers in health and disease have differences in the percentage of naïve, memory, plasma-
blasts, and plasma cell B cell populations, and corresponding differences in gene expression that may highlight
disease-relevant pathways downstream of the variant. Upon completion of this study, we will have exhaustively
tested variants for their ability to alter cis-regulatory activity in MPRA in B cells and followed up on high effect
variants to determine their biological relevance to disease. Mechanistic dissection of these prioritized risk
variants could provide a wealth of targetable pathways for which to design new therapeutics for autoimmunity.

Public health relevance
PROJECT NARRATIVE Autoimmune diseases are genetically complex, so it is hard to identify whether people are at risk and what causes autoimmunity. In this proposal, we will use a highly effective test in B cells, a relevant cell type in autoimmunity, to determine the specific regions of the genome that contribute to disease, and we will confirm our results through engineering these risk regions into human cells and observing their effects on B cells from healthy and autoimmune subjects. Collectively, this work will be helpful for finding what causes autoimmunity and for creating better treatments.